Distinct roles of chromatin regulation in transcriptome and genome maintenance in corticogenesis

PROJECT SUMMARY/ABSTRACT
Biological processes on nuclear DNA occur in the context of chromatin. The precise regulation of transcription,
DNA replication, and DNA damage repair requires dynamic control of histone mobility orchestrated by chromatin
regulation. The multiple roles of chromatin regulation in neurodevelopment are being unraveled. Recent studies
have revealed that cell fate specification, neural plasticity, and circuit formation are mediated, in part, by
chromatin. Mechanistically, chromatin modulates these developmental processes via transcriptomic regulation.
Chromatin, however, also plays an essential role in genome maintenance. Genome integrity is particularly
important in rapidly dividing stem cells, including neural progenitor cells (NPCs). DNA replication and DSB repair
each occur in the context of chromatin, which must be reorganized for all transactions on DNA, including
replication fork progression, DSB detection, and recruitment of DNA repair factors. These processes are
mediated by chromatin remodelers – ATP-dependent protein complexes that can reposition nucleosomes on
DNA, evict nucleosomes from DNA, or exchange histone subunits, thus controlling the accessibility, flexibility,
and mobility of chromatin. In striking contrast to the well-known transcriptional roles of chromatin, the equally
important functions of chromatin regulation in genome maintenance are virtually unexplored in neural
development. Here, the proposed work builds on our recent paper on the chromatin remodeler Ino80 (Keil et al.,
2020), in which we find dissociable roles for Ino80 in YY1-associated transcriptional regulation and homologous
recombination (HR) DNA repair in cortical NPCs. Notably, impaired DNA repair is the driver of neuroanatomical
phenotypes following Ino80 deletion, thus demonstrating that this underexplored role of chromatin can effect
neurodevelopmental consequences. Importantly, Ino80’s DNA repair function is not unique among chromatin
remodelers. In this application, we seek to investigate a potentially wider role of chromatin remodeling in DNA
damage and repair in NPCs. We will apply our expertise in chromatin biology, DNA damage repair, functional
genomics, and genetics to: 1) dissect distinct chromatin remodeling functions in transcriptional regulation versus
genome maintenance; 2) determine the mechanisms of chromatin remodeling functions in DNA replication and
damage repair; and 3) assess the brain somatic genome consequences of chromatin remodeling dysfunction.
Recent human genetic findings have convergently implicated chromatin dysregulation in neurodevelopmental
disorders. Here, we propose that, in addition to transcriptional regulation, chromatin remodeling plays an equally
important role in genome stability across NPC divisions. This aspect of chromatin function is largely unexplored
in brain development. Our study will address this important gap in the field and mechanistically dissect the distinct
roles of chromatin remodeling in transcriptional regulation versus genome maintenance in neurodevelopment.

Public health relevance
PROJECT NARRATIVE Genomic DNA is packaged into a compact form around chromatin, which is a highly organized complex of DNA and proteins that needs to be reorganized by chromatin remodelers to enable biological processes such as gene expression, DNA replication, and DNA damage repair. Recent human genetic findings have indicated that mutations in genes encoding chromatin remodelers are an important contribution to disorders of brain development, including autism spectrum disorder and intellectual disability. In this study, we seek to understand the distinct functions of chromatin remodeling in gene expression and DNA damage and repair, and the consequences of their disruption on the development of the brain.